OCCUPATIONAL SAFETY AND HEALTH EDUCATION AND RESEARCH CENTERS (T42)

﻿
DESCRIPTION (provided by applicant): The goal of the Northern California NC-ERC, a consortium of programs of the University of California, is to train professionals as practitioner and research leaders in occupational safety and health by offering graduate degrees, residency training, clinical experiences, and research mentorship to trainees. The aim of the NC-ERC Is to provide a broad, multidisciplinary education experience involving student and faculty collaborations in the classroom and on research and service projects. Activities are grounded in multi-campus, interactive teaching programs that translate knowledge Into Information that can be used to improve worker safety and health. In addition, through the Confining Education and Outreach components of the Labor Occupational Health Program, the NC-ERC provides continuing education courses and outreach activities to other health professionals. The Center aims to provide an educational bridge from the University to external constituencies to ensure that practicing professionals, workers, their representatives, supervisors, and other educators benefit from the University's occupational health and safety expertise. The NC-ERC strives to integrate an occupational safety and health perspective in all of its activities, including such activities as the Short Term Educational Experiences for Research (STEER) program, summer internships funded by the National Institute for Environmental Health Sciences, designed to encourage students to consider further study in one of the NC-ERC programs. The Northern California NC-ERC trains professionals in the following areas: Industrial Hygiene (UC Berkeley) - MPH, MS, PhD degrees; Epidemiology (UC Berkeley) - MPH, MS, PhD degrees; Occupational and Environmental Health Nursing (UCSF) - MS, PhD degrees; Occupational and Environmental Medicine (UCSF) - Residency Training. MPH degrees; Ergonomics (joint program at UCB/UCSF) - MS/MPH, PhD degrees; Targeted Research Training (joint program at UCB/UCSF) and proposed Agricultural Safety & Health Program - PhD degree.

DESCRIPTION (provided by applicant): The aim of the NC-ERC training program is to produce graduates with strong problem solving skills and the ability to synthesize diverse information in order to effectively address both typical and unusual problems that arise in the technically, institutionally, and culturally complex workplaces that characterize the current economy. Issues facing low-wage and immigrant workers are particularly important to the NC-ERC, as are health and safety issues in emerging sectors such as green jobs.